Ultramicrotome with necessary accessories

Project Summary/Abstract
Funds are requested to purchase a Leica ARTOS ultramicrotome with necessary accessories including a
vibration isolation instrument table, diamond knives, and a glass knifemaker. Included with the purchase will
be training for the major users and the core facility staff member responsible for overseeing use of the
instrument. The instrument will be housed in the campus Molecular Cytology Core Facility (MCC) where it will
replace an ultramicrotome that is over 30 years old and in disrepair. The existing instrument can no longer be
serviced due to its age and lack of replacement parts. The ultramicrotome is essential for the research being
conducted by members of a large user group. Research by the users that requires this instrument includes
studies on hereditary neurodegenerative and retinal degenerative diseases, amyotrophic lateral sclerosis, dry
eye diseases, connective tissue disorders, lysosomal storage diseases and cancer. The new instrument will
enable the investigators to prepare tissue sections for both light and electron microscopic (EM) examination.
The instrument will enable users to produce ribbons of serial sections that can be used to generate 3-
dimensional images of tissues and cellular structures of interest using advanced light microscopy equipment
(including confocal microscopes) at the MCC and electron microscopy capabilities of the University Electron
Microscopy Core Facility (EMC) to obtain images for array tomography. The 3-D images will enable the
investigators to address important research questions that cannot be addressed using microtomy
instrumentation currently available at the University. For example, it appears that impaired retinal function in
several hereditary disorders under investigation may be due to alterations in the synapses between retinal
neurons. It is very difficult to determine whether this is the case by examining individual thin sections with TEM
or with immunofluorescence (IF) using confocal microscopy alone. If the users can collect serial sections
encompassing entire synaptic structures and generate 3-D composite images that can be examined with both
EM and immunofluorescence, the users will be able to reliably determine whether there are disease-related
structural alterations in the synapses that could explain the functional deficits. Numerous projects of anticipated
users would benefit from having the capability of performing correlative IF and EM with array tomography. The
information that users will be able to glean using the ultramicrotome will assist in developing better
understanding of pathogenesis and in developing effective therapies for numerous disorders. In addition to
benefiting the biomedical research of users that are identified in this proposal, the ultramicrotome has the
potential to facilitate the research of additional potential biomedical researchers. Many laboratories utilize the
MCC for a variety of microscopy techniques and digital image processing. Through their work in the MCC
facility, they will become aware of the availability of the ultramicrotome and its capabilities and may elect to use
it in their research.

Public health relevance
Project Narrative Funds are requested for the purchase of an ultramicrotome by a group of faculty investigators at the University of Missouri. This instrument will facilitate research on a variety of diseases including hereditary neurodegenerative disorders, diseases of the eye, and connective tissue disorders.